Genomics Core

GENOMICS CORE D
PI: Dr. Sebra
PROJECT SUMMARY
Recent advances in genomics technology and associated data analysis methods have provided
a framework to interrogate the human host response to vaccination and the dynamic interplay
between host and pathogen during viral infection at an unprecedented resolution. The integration
of molecular and cellular data alongside clinical metadata and serologic data nucleates the
potential to identify signatures of viral immunity outcomes by characterizing changes in innate
immunity before and after vaccination. However, no single technology is sufficient to address the
multitude of open questions raised by deep molecular immune profiling, necessitating an
integrated approach for profiling immunity and vaccine response. Analysis of PBMCs and
histocultures across VIVA projects with a variety of cutting-edge and custom high throughput,
molecular and high-resolution multi-omics technologies will provide the best database for vaccine
immune responses across these systems. The VIVA Genomics Core D aims to leverage a data
generation technology suite inclusive of bulk RNAseq, serologic data, single cell CITEseq,
CyTOF, spatial transcriptomics, viral genomics and multi-scale computational approaches for the
comprehensive characterization of immune response to predict vaccine outcomes. Using the
integration of these data, Core D will deliver multi-omics data generation and quality control for
seamless analysis, integration and annotation with the Genomics Data Analysis and Management
Core E across VIVA projects including the Immune/Clinical Core, Project 1 (SARS-CoV-2),
Project 2 (seasonal influenza), Project 3 (tetravalent DENV). Core D will serve as an invaluable
resource for the VIVA HIPC team coupling molecular data generation and Core E data driven
approaches to foster technology refinement and development and promote collaboration between
VIVA projects.